Testing the Efficacy of Mindfulness-Based Stress Reduction Combined with Behavioral Parent Training in Families with Preschoolers with Developmental Delay

7. Project Summary/Abstract
This application builds on our previous intervention work (e.g., McIntyre, 2008a, 2008b, 2013; McIntyre &
Neece, 2016; Neece, 2014) and proposes a longitudinal intervention study of 230 preschool-age children (ages
3–5 years) with developmental delays (DD). Behavior problems and co-occurring parenting stress are common
problems in children with DD and their families. High levels of parental stress are associated with reduced
response to behavioral interventions for children with DD; yet, parenting stress is almost never directly
addressed in these treatments (McIntyre & Neece, 2016). The proposed study will test the benefit of
addressing parental stress prior to delivering behavioral parent training (BPT) in order to more effectively
reduce child behavior problems once the intervention is delivered, as well as investigate the mechanisms
through which intervention outcomes occur. The study design will use a cross-site randomized, controlled trial
(RCT) of standard behavioral parent training with psychoeducation (BPT-E) compared with behavioral parent
training plus mindfulness-based stress reduction (BPT-M). The sample will be drawn from Lane County,
Oregon, and the Inland Empire in Southern California. All families will participate in home and laboratory
assessments at baseline and home assessments immediately posttreatment, as well as at 6 months and 12
months posttreatment. Measures include standardized and validated self-report and teacher-report
questionnaires, gold-standard psychological assessments, and observational measures. The primary outcome
of interest is child behavior problems. Analyses will be conducted using standard normal theory regression and
structural equation modeling techniques, with a particular focus on latent growth modeling. Primary intent-to-
treat efficacy hypotheses comparing the BPT-E with BPT-M will be specified within a set of sequential mediation
analyses. The proposed study is a cross-site RCT with a PI at each site. Dr. McIntyre (MPI, University of
Oregon) has more than 15 years of experience working with children with DD and their families. Her research
has focused on early intervention and prevention of behavior problems. Dr. McIntyre adapted the BPT
intervention used in this study and has completed two RCTs assessing the efficacy of this intervention (R03
HD047711 and R01 HD059838). Dr. Neece (MPI, Loma Linda University) has more than a decade of
experience working with children with DD, and during the past 5 years has studied the feasibility and efficacy of
MBSR for a diverse sample of parents of preschool children with DD. Drs. McIntyre and Neece have engaged
in collaborative research for more than 10 years and have coauthored publications focused on family factors
predictive of behavioral outcomes in children with developmental disabilities.

Public health relevance
8. Project Narrative This application proposes a longitudinal study of preschool-age children (ages 3–5 years at study entry) with developmental delay randomized to a standard behavioral parent training intervention with psychoeducation (BPT-E) or to a behavioral parent training intervention enhanced with mindfulness-based stress reduction (BPT- M) to reduce children's problem behavior and improve parenting skills and parenting stress. The efficacy of this approach will be evaluated, specifically allowing us to quantify the additive benefit of mindfulness-based stress reduction. The study will significantly contribute to our understanding of the emergence of childhood behavior disorders and mental health problems in boys and girls with developmental delay, and the intervention, if successful, could be cost effectively implemented across the United States within early education and health delivery systems.